High-throughput Discovery of Antibodies against Understudied Membrane Proteins

ABSTRACT
Of the 20,000 genes in the human genome, approximately 4,000 are considered “druggable” by
pharmaceuticals. However, less than 10% of these druggable proteins are actually targeted by FDA-approved
drugs. In 2014, the Illuminating the Druggable Genome (IDG) project was launched by the NIH in recognition
that there is a potentially large number of druggable targets with high therapeutic value that are undiscovered
or understudied. The IDG selected 230 G protein-coupled receptors (GPCRs) and ion channels as a focus of
their program, as these families make up the largest families of the druggable genome and have high potential
to impact human health. Due to their difficult biology, many of them are completely unexplored. To enable this
research, the IDG has called for the development of reagents such as monoclonal antibodies (MAbs) against
these 230 GPCRs and ion channels, only 10% of which currently have commercially available MAbs. A novel
approach to identify membrane protein MAbs in a high-throughput manner is needed to derive MAbs against
the entire druggable human membrane proteome.

Public health relevance
PROJECT NARRATIVE This proposal will contribute to public health and the cure of human disease by generating high quality MAbs against understudied membrane proteins, enabling their development for biomedical research and potentially therapeutics. Lack of tools has hindered experimental efforts to understand these proteins and their therapeutic capabilities, and as part of the Illuminating the Druggable Genome (IDG) program, there is a need to develop accessory reagents for use in downstream studies. This proposal was prepared in response to this call for action.